Gasdermin E-mediated pyroptosis in promoting antitumor immunity and cancer treatment

Project Summary/Abstract
The majority of cancers, which are immunologically “cold” with limited T cell infiltration, show abysmal response
rates to immunotherapy. Novel strategies to enhance recruitment and functions of tumor-infiltrating lymphocytes
(TIL) are urgently needed to improve cancer immunotherapy. How cancer cells die in response to stress,
cytotoxic lymphocytes, and drugs has a profound impact on the immune landscape of cancer. While most cancer
cell death has been viewed as noninflammatory, our recent study showed that pore-forming protein Gasdermin
E (GSDME), when expressed in tumor cells, converts noninflammatory apoptosis to pyroptosis, a highly
inflammatory form of programmed cell death. GSDME potently inhibits tumor growth and enhances the numbers
and antitumor functions of CD8+ and NK TILs. The tumor-inhibitory effect of GSDME is mediated by TIL killing
of GSDME+ target tumor cells, which can also trigger tumor cell pyroptosis. Our study suggests that promoting
cancer cell pyroptosis has excellent potential to improve cancer immunotherapy, but it remains unclear how
GSDME-induced pyroptosis boosts antitumor immunity. The proposed research aims to investigate how tumor
GSDME expression shapes the tumor-infiltrating immune cells and their interactions to increase tumor immunity,
and to develop a novel strategy to promote inflammatory cancer cell death, with the long-term goal to enhance
immunotherapeutic efficacy for cancer patients. Specifically, I will study how damage-associated molecular
patterns (DAMPs) produced by GSDME+ tumor cells modulate the composition, maturation, and functions of
tumor-infiltrating dendritic cells (TIDCs) and tumor-associated macrophages (TAMs), key players to induce
potent antitumor T cell response, by using CyTOF and inhibitors of DAMPs or their receptors (Aim 1). Aided by
single cell (sc)RNA-seq and bone marrow chimeric mice, I will study how different TIDC subsets interact with
CD8+ TILs to promote GSDME-mediated antitumor immunity (Aim 2). As many cancer cells epigenetically silence
GSDME and RIPK3 (key mediator of necroptosis, another inflammatory form of cell death) via promoter
hypermethylation, I will investigate whether the DNA methylation inhibitor decitabine could promote cancer cell
pyroptosis and necroptosis to suppress tumor growth and enhance antitumor immunity (Aim 3). These studies
will greatly advance our understanding of GSDME’s immunostimulatory mechanism and offer new opportunities
to revitalizing immunotherapeutic efficacy for patients with uninflamed “cold” tumors. My career goal is to lead
an independent academic laboratory addressing questions on cancer immunology and immunotherapy. In the
K99 phase, I will take full advantage of the extensive resources at the vibrant research community of Harvard
and the outstanding team of mentors and collaborators to receive comprehensive training in advanced
technologies, bioinformatics, mouse models, and translational research, to further establish collaborations and
sharpen my professional skills. The proposed training plan will serve as a superb roadmap that will lead me to
my goal of succeeding as an independent investigator, and to make a difference in the lives of cancer patients.

Public health relevance
Project Narrative “Cold” tumors with few infiltrating T cells are mostly unresponsive to current immunotherapies, strategies that could enhance T cell tumor recruitment and functions hold great promise to advance the efficacy of immunotherapy and are urgently needed. Our recent work shows that Gasdermin E (GSDME)-mediated cancer cell pyroptosis, a highly inflammatory form of programmed cell death, potently inhibits tumor growth and boosts antitumor functions of CD8+ T cells. My proposal aims to investigate how GSDME-mediated pyroptosis modulates tumor-infiltrating immune cells and their interactions to boost antitumor immunity, and to develop novel approaches to promote inflammatory cancer cell death, with the goal to identify better drug targets and more robust therapeutic strategies to improve cancer treatment.